CORE--MOLECULAR BIOLOGY

Molecular biology and tissue culture are basic techniques used in the analysis of developmental anomalies. As molecular biology plays an increasingly important component in all the elements of such gene search and characterization strategies, consistent and standardized approaches to many of the techniques have been developed. Investigators in this project can benefit from having access to a core that can provide a standard set of protocols and reagents to facilitate the development of their own particular asks. Tissue culture will continue to provide modest services to establish and maintain lymphoblastoid cell lines on a selected group of patient-based materials for which access to cell lines in the future may be beneficial. A large component of core activities will be devoted toward sample cataloguing and DNA extraction protocols for the large number of samples identified in Project 1 and being analyzed in Projects 2 and 3. Finally, a resource for standardized plasmid preparation with delivery to a DNA sequencing facility will be maintained that will allow for quick and inexpensive automated DNA sequencing to be provided to Projects 2, 3 and 4. It is expected that the centralization of these resources for both tissue culture and molecular biology will decrease duplication of effort and serve to greatly increase the productivity of the center as a whole.